NARCH 11 Administrative CORE

Program Summary-Abstract
The overall goals of the CA-NARCH Administrative Core are to support the educational and research
efforts of the CA-NARCH Student Development Program and to provide critical ongoing community-
based participatory tribal direction. The administrative structure of the CA-NARCH has evolved through
funding from NARCH III, NARCH V, NARCH VII, and NARCH X and consists of the IHC Executive
Team, Dan Calac PI, Stephanie Brodine Program Director, Corinne Davidson/McDaniels Research
Director, and the CA-NARCH Tribal IRB. The CA-NARCH CORE supports the center components to
fulfill the overall NARCH mission to implement health research projects prioritized by the area tribes,
reduce mistrust in research among AI/AN, enhance the research capacity and partnerships to reduce
AI/AN health disparities, and develop a cadre of AI/AN health research professionals. The CA-NARCH
is based at Indian Health Council (IHC), and non-profit clinic that supports a consortium of 9-tribes in
San Diego County. The CA NARCH XI Administrative Core will help fulfill the major aims and goals
of all Center components by pursuing the following specific aims: 1) To provide leadership and
management, including administrative and fiscal oversight of the CA-NARCH student development
project; 2) To coordinate communication and dissemination of information between the local tribes, tribal
leaders, and the student development program team; 3) To support the cultural interface and augment
research ethical training in the SDP with biannual workshops led by the Tirbal IRB chair and members; 4)
To seek out and disperse information on funding opportunities through NARCH and other sources for
continued development of training and mentoring programs and/or research projects; 5) To evaluate
progress of the CA-NARCH in achieving its objectives and milestones. The specific aims will support the
efforts of the CA-NARCH mission of conducting highly relevant, American Indian/Alaskan Native
(AI/AN) community-based research and establishing a trained cohort of AI/AN scientists dedicated to
impacting the health disparities of AI/AN populations. Activities in the CA-NARCH are also evaluated
by the CA-NARCH IRB, which is officially registered with the U.S. DHHS Office of Human Subjects
Research Protection (OHRP) as #IRB000041401 and has received Federal-wide Assurances approval
under Indian Health Council, Inc., and is registered as #FW00006757. This work shall also strive to
establish a replicable model partnership for tribal nations and academic organizations.

Public health relevance
Program Narrative The CA NARCH XI Administrative Core will help fulfill the major aims and goals of all Center components by pursuing the following specific aims: 1) To provide leadership and management, including administrative and fiscal oversight of the CA-NARCH student development project; 2) To coordinate communication and dissemination of information between the local tribes, tribal leaders, and the student development program team; 3) To support the cultural interface and augment research ethical training in the SDP with biannual workshops led by the Tirbal IRB chair and members; 4) To seek out and disperse information on funding opportunities through NARCH and other sources for continued development of training and mentoring programs and/or research projects; 5) To evaluate progress of the CA-NARCH in achieving its objectives and milestones. The specific aims will support the efforts of the CA-NARCH mission of conducting highly relevant, American Indian/Alaskan Native (AI/AN) community-based research and establishing a trained cohort of AI/AN scientists dedicated to impacting the health disparities of AI/AN populations.